Developing Training Materials for Experimental Rigor in Neuroscience

Project Summary
In this project, we propose to develop training modules to address three main topics:
1. Designing rigorous experiments.
2. Reducing effects of bias.
3. Supporting best practices for open data and transparency.
Our team will help to create engaging content that is well-suited to undergraduate and
graduate student education. We will develop modules that use neurological disorders and
stroke as a focus, offering connections to biomedical research on human disease that are
relevant to students' lives. Our modules will incorporate our commitment to diversity, equity
and inclusion. We will bring our expertise as laboratory scientists who train early career
students, our extensive experience as skilled classroom instructors, and our confidence that
public action can improve rigor and reproducibility in science.

Public health relevance
Project Narrative Training scientists in principles of rigorous experimental methods is essential to maintain the high quality of our biomedical research. In this grant we will work collaboratively to develop engaging and effective training materials to achieve improved training in rigor and reproducibility.